Improving Racial Equity in Clinical Decision Making about Access to Organ Transplant

PROJECT SUMMARY
Organ transplantation is the optimal treatment for end stage organ disease and results in improved patient survival and
quality of life. Black patients have rates of end stage organ disease nearly three times that of white patients, yet comprise
only 20% of organ transplant recipients. The transplant selection process is not standardized across transplant centers and
therefore decision making at each phase of the process is potentially vulnerable to institutional racism. Further, national
transplant data collection and monitoring exclude the transplant selection process. The overall objective of this proposal
is to identify, characterize, and intervene on inequities in organ transplant that occur due to health system processes
which are vulnerable to interpersonal and institutional bias Our central hypothesis is that inadequate attention to equity
promoting principles throughout each phase of the selection process are major contributors to inequitable access to organ
transplant. This project will quantify racial inequities at each phase of the transplant selection process (screening,
evaluation and committee decision making) using electronic health record data, characterize vulnerabilities in the
transplant screening, evaluation and committee decision aming processes that contribute to overall inequities in access
to transplant and design and pilot a toolkit to reduce inequities in the transplant screening, evaluation and committee
decision making processes. This results of this project will elucidate the influence of institutional racism in transplant
systems and processes on racial equity in access to transplant. The research and additional knowledge and skill
development will form a strong foundation for the candidate’s transition to an independent investigator studying
interventions to overcome institutionally biased practices which contribute to organ transplant inequities.

Public health relevance
PROJECT NARRATIVE The proposed project will generate new knowledge of the magnitude and mediators of inequities at each phase of the transplant selection process and how institutional racism embedded in center-level processes and individual clinician biases may influence inequities. The results will elucidate the influence of institutional racism in transplant systems and processes on racial equity in access to transplant. In the future, Our toolkit will represent the first intervention developed to overcome bias and mitigate inequities at each step in the transplant selection process. In the future, we hope implement our toolkit at multiple transplant centers to test its ability to mitigate institutionally biased practices which contribute to organ transplant inequities.